ID OF NOVEL BREAST CANCER AGENTS BY FUNCTIONAL GENOMICS

Our goals are to develop novel methods which rapidly identify genes and lead pharmaceutical compounds in the area of breast cancer. We have developed a gene-tagging method which uses highly sensitive B-lactamase (bla) reporter system to rapidly 1) screen for novel genes with expression profiles responsive to the presence or absence of estradiol, and 2) identify drug candidates with specificity/efficacy profiles different from existing drugs. We hypothesize that this gene tagging strategy can be used to create a set of stably transfected breast cell lines expressing inducible/repressible genes and to rapidly screen for novel anti- cancer agents which prevent modulation of those genes. PROPOSED COMMERCIAL APPLICATION: 1.4 million new cancer cases were estimated in 1997 in the U.S. with medical costs of $35 billion. Sales for breast cancer drugs tamoxifen and taxol are close to $500 million and $800 million respectively. However, standard endocrine drug therapy as well as chemotherapy and treatment with taxoids fail to treat recurring breast cancer. Hence, there is a need for more and improved agents for treatment of recurring and hormone independent breast cancer.